Stanford University Regional Coordinating Stroke Center for the NIH Stroke Trials Network

The Stanford Stroke Center, one of the first comprehensive multidisciplinary centers of its kind, was
established in 1992 to develop new approaches to diagnose and treat stroke. The mission of the Stroke Center
is to be the best comprehensive organization in the United States focused on stroke diagnosis, treatment,
research, and education. In 1992, the Center was established by a team of neurologists, neurosurgeons,
neuroradiologists, nurse specialists, basic scientists, and clinical researchers. This multi-disciplinary team has
met regularly to continually refine the program for 25 years. In 2012, the Joint Commission and the American
Heart Association/American Stroke Association announced that the Stanford Stroke Center was the first
hospital in the United States to meet The Joint Commission's standards for Disease-Specific Care
Comprehensive Stroke Center Certification.
Stanford was chosen to be one of the original StrokeNet Regional Coordinating Centers (RCCs). During the
initial grant period, Stanford developed the DEFUSE 3 study, which became the first clinical trial to be funded
and executed by StrokeNet. This 40-site trial has been extremely successful; enrollment rates were
substantially ahead of projected targets and the trial was stopped early by the DSMB because of a high
probability of efficacy in the endovascular group. Stanford's regional network is one of the highest enrollers in
StrokeNet studies and Stanford faculty have made major contributions to key StrokeNet committees. The
Stanford-RCC will continue to provide high volume enrollment of diverse patient populations into NINDS
funded stroke trials. The Stanford RCC will also continue to offer an innovative multidisciplinary fellowship
program that provides comprehensive training in clinical trial design, implementation and analysis. In addition,
Stanford faculty members will continue to propose new clinical trials for implementation through StrokeNet.

Public health relevance
The Stanford Stroke Center has developed a comprehensive stroke network consisting of 6 comprehensive stroke centers that provide a high volume of patient enrollment into NINDS funded stroke trials. Our StrokeNet fellowship program provides comprehensive training in clinical trial design, implementation and analysis. In addition, Stanford faculty members propose new clinical trials for implementation through the NINDS Stroke Network.